Biomedical Informatics

PROJECT SUMMARY
The objective of the Biomedical Informatics Shared Resource (BI-SR) is to provide collaborative and consultative
services to Stanford Cancer Institute (SCI) members and thereby to add value in all phases of cancer research.
Consultation is provided on identifying clinical data, both retrospective and prospective, along with associated
omic or trial data as necessary to support the basic and translational research efforts of a discovery-oriented SCI
research community. The BI-SR has developed tools for the retrieval and coding of data for analysis and
visualization with attention to data quality and reproducibility. The BI-SR was split out from the previous
Biostatistics and Research Informatics SR in 2017 and now operates under the direction of Daniel Rubin, MD.
The core resource supported by the BI-SR is the Stanford Cancer Institute Research Database (SCIRDB), with
a full menu of services provided by the BI-SR staff for data query and data vending. The SCIRDB database has
continued to be developed to meet the needs of SCI members to collect, integrate, and analyze both identified
and de-identified patient data from the electronic health record (EPIC) and from a wide range of other data
sources, including Pathology, Molecular Diagnostics, clinical trials, and other clinically-related databases. The
BI-SR also provides consultative services to ensure its optimal use. Significant contributions in this funding period
included the introduction of new data (incorporation of imaging and genetic data) and the development of new
software tools for federated learning of artificial intelligence (AI) applications, as well as improvement in data
science infrastructure by commencing migration to the cloud. Members of all programs use the BI-SR, with the
heaviest use coming from the Cancer Therapeutics and Hematologic Malignancies programs. The BI-SR has
engaged in over 250 project consultation requests and provided data to over 100 cancer studies, resulting in
over 15 cancer-focused publications since 2017. Two of these were high-impact publications. The annual budget
of the BI-SR is $746,394, yet the CCSG request is $55,879. Accordingly, the BI-SR leverages extensive
institutional support and seeks only 7% from CCSG funds. The BI-SR is focused on four specific aims: (1) to
maintain and continue to develop the SCI Research Database (SCIRDB) to catalyze cancer research, (2) to
provide SCI members with data science services and technologies to enable cancer research, (3) to develop
infrastructure and data-driven applications to support the needs of cancer disease groups and researchers, and
(4) to educate SCI members about the opportunities BI-SR’s technologies provide for enabling data-driven
cancer discovery and care.